Translational BioPhotonics/Additive Manufacuring for Biophotonics

This proposal seeks support for the Translational BioPhotonics / Additive Manufacturing SPIE
conference to expand participation of students and young researchers. The financial support
will be used to cover their registration fee. The meeting is the 5th in series of Translational
BioPhotonics, and 2nd in Additive Manufacturing for Biohotonics and Bioprinting Applications.
The format of the meeting is built around invited talks from top specialists in their respective
fields and contributed poster session. The mission of the conference is two-fold: (1) connect
academics, clinicians and industry in one forum and present complete process of defining
diagnostic need and clinical perspective (clinical perspective), development stage (different
stage of development from early concepts to more mature technologies by academics), and
finally translation/commercialization phase (by Industry). The second purpose (2) is to enable
interaction between early stage researchers and established/experienced investigators. The
specific areas presented at the conference include imaging and biophotonic solutions for
diagnostics, guided therapy and point of care applications. The meeting is highly regarded by
Biophotonics Community and this R13 mechanism to make it more accessible for students /
early career researchers.

Public health relevance
The Translational Biophotonics + Additive Manufacturing conference is a meeting to allow effective interaction of Clinicians, Academics and Industry toward effective technology translation to clinical practice.